Clinical Trial Advancement and Development for Sarcomas

ABSTRACT
Suitability. Dr. Harris is well-suited for the Early Career Cancer Clinical Investigator Award (ECIA). His clinical
trial interests and career plans focus on optimizing outcomes with radiation therapy for sarcomas.
Planned Activities. Clinical Trial Training. Dr. Harris will enroll in the SWOG Early Career Training Course.
This course involves one-on-one mentorship, a course, and an in-person workshop. Dr. Harris will also enroll in
Clinical Trials Project Management, a project management course at the University of California Irvine (UCI).
Mentorship Plan. Dr. Harris has identified Dr. Warren Chow, a leader in sarcoma clinical trials at UCI, and Dr.
Lara Davis, head of the SWOG Sarcoma Working Group and co-chair of S2505. Dr. Harris will meet regularly
and work with both mentors throughout the ECIA period.
Cancer Committee Involvement. At the UCI Cancer Center level, Dr. Harris will continue his role on the data
safety monitoring committee. He will take on an additional role on the Children’s Hospital of Orange County
(CHOC)/UCI Research Collaboration Committee. At the National Clinical Trials Network (NCTN) level, Dr. Harris
will continue his membership roles on SWOG and NRG Committees - SWOG Sarcoma Working Group, SWOG
Radiation Oncology Committee, SWOG Early Therapeutics and Rare Cancers Committee, NRG Sarcoma
Working Group, and NRG Developmental Therapeutics RT Committee.
Clinical Trial Enrollment and Completion. Dr. Harris led the first two investigator-initiated trials in the
Department of Radiation Oncology at UCI – one for sarcoma (UCI 21-03, NCT05488366, funded through the
UCI Anti-Cancer Challenge Grant under NCI P30CA062203) and another for lung metastases (UCI 21-222,
NCT05555342, funded through the American Cancer Society Seed Grant). UCI 21-03 tests the combination
pembrolizumab with radiation therapy. During the ECIA period, Dr. Harris will complete trial accrual, perform
analysis, and submit the manuscript. S2505 is a SWOG concept that Dr. Harris chairs: “Phase III Randomized
Study Testing Non-Inferiority of Shorter-Course Radiation Versus Standard Fractionation for High-Risk,
Resectable Sarcoma”. S2505 will be submitted to NIH CTEP prior to ECIA period. In Year 1 the protocol will be
drafted, and in Year 2 site initiation and central radiation plan review will take place. Opening new NCTN trials at
UCI. Dr. Harris will open EA7201 and ARST2031 at UCI.
Expanding awareness of sarcoma clinical trials. UCI: Dr. Harris will take on a new role in the Sarcoma Tumor
Board including a monthly overview of all open, accruing, and upcoming clinical trials in sarcoma to expand
awareness and increase enrollment. Community: Dr. Harris will co-develop culturally tailored educational talks
on clinical trials with the office of Community Outreach and Engagement. He will deliver these talks and
emphasize how clinical trials offer treatment options for common cancers plus rare cancers like sarcomas.

Public health relevance
NARRATIVE Dr. Harris’s clinical trial interests and career plans focus on optimizing outcomes with radiation therapy for sarcomas, including through expansion of NCI-funded trial enrollment. During the ECIA award period, he will enroll in a clinical trial project management course at UCI and the Early Career Training Course through SWOG. Dr. Harris will also work with mentors to complete his NCI-funded sarcoma trial (UCI 21-03) and launch a phase III clinical trial through SWOG (S2505).